The role of stem-like CD8 T-cells in the abscopal response

PROJECT SUMMARY
Prognosis is poor for patients diagnosed with locally advanced melanoma. Survival outcomes are improved
with checkpoint blockade in the neoadjuvant, adjuvant and unresectable setting. Dual checkpoint blockade
further enhances outcomes, but often at the cost of significant clinical toxicity. Despite this progress, for the
more than 40% of patients who do not respond, outcomes remain dismal. There is a clear need to develop
innovative treatment approaches with higher response rates and less toxicity. Radiation (RT) has immuno-
stimulatory activity capable of inducing an anti-tumor CD8+ T cell response within and outside of the irradiated
field - an abscopal effect. In preclinical and clinical studies, RT’s immuno-stimulatory activity synergizes with
checkpoint blockade (αPD-1) to significantly improve tumor control with limited toxicity. Despite the
encouraging clinical potential of RT + αPD-1, the abscopal effect still only occurs in a minority of patients. To
determine innovative methods to enhance the abscopal effect, we evaluated tumor-directed RT’s impact on
different CD8+ T-cell subsets in a murine model. The Ahmed lab has shown an exhausted PD-1+ T cell subset,
stem-like CD8+ TCF-1+ T cells, are essential for robust αPD-1 responses. Dendritic cell (DC) provided peptide-
MHC and co-stimulation along with αPD-1 stimulate stem-like T cell expansion and differentiation into terminal
effector cells capable of tumor killing. I have shown this stem-like subset is primarily localized to the tumor-
draining lymph node (TDLN). Strikingly, tumor-directed RT alone stimulates maturation of DCs and proliferation
of this subset in the TDLN. This proliferative response following RT, independent of αPD-1, suggests a novel
RT induced mechanism for T-cell reinvigoration which may be exclusively DC dependent. Notably, for locally
advanced or high-risk melanoma patients, immunostimulatory therapy (RT and/or αPD-1) are typically given
following tumor and TDLN removal. This current approach reduces the immuno-stimulatory potential of either
treatment compared to their administration with an intact TDLN. Importantly, combination pre-operative αPD-1
and RT have not been investigated in locally advanced or high-risk melanoma. Based on these preliminary
results, our central hypothesis is that the stem-like CD8+ T cells in the TDLN are important mediators of the Tumor-
RT stimulated anti-tumor abscopal effect. To test this hypothesis, we will: (1) determine the role of the stem-like
CD8+ T cells in the abscopal effect; (2) determine whether dendritic cell mediated stimulation is critical for RT
induced stem-like T cell expansion in the TDLN; (3) determine whether neoadjuvant Tumor-RT with αPD-1 is
associated with increased stem-like CD8+ T cell infiltration in locally advanced melanoma in a pilot human
study. Results of this proposal may identify a novel mechanism for overcoming T-cell exhaustion which has
less immunologic toxicity with increased anti-tumor efficacy. Clinically, it may redefine the standard approach
of surgical removal or irradiation of the TDLN due to the lymph node’s importance in the abscopal response.

Public health relevance
PROJECT NARRATIVE Combined radiation and checkpoint treatment has shown clinical potential for advanced malignancies including melanoma, however, responses outside the radiation field (abscopal effect) still occur in only a minority of patients. This proposal may provide important insight into a novel mechanism for anti-cancer T cell stimulation which is less toxic and has higher local and distant response rates than current approaches. In addition, it may lead to a re-evaluation of the need for and benefit of surgical removal of the tumor-draining lymph nodes.